Rational design of a novel rapid diagnostic tool for coccidioidomycosis

Coccidioides immitis and C. posadasii are two species of soil fungi that cause the disease coccidioidomycosis,
(or Valley fever), whose incidence has increased 587% over the last 20 years and now causes over 150,000
new infections in the United States annually. The Centers for Disease Control and Prevention (CDC) report that
average cost for treating Valley fever is over $50,000 per patient and delays or misdiagnosis of Valley fever
result in an average of $590,000 in extra healthcare costs, including extensive hospital stays and a lifetime of
treatment. Current Valley fever diagnostic tests are based on proprietary antibodies or antigens, which may not
be easily accessed. We propose that advanced genomic analyses of these fungal pathogens can support the
identification of new biomarkers and embody the foundational framework that is necessary for development of
new diagnostic tools. We aim to improve the diagnostics available for detection of Coccidioides spp. by analyzing
existing genomic data and using in silico predictions to identify several putative antigens that are highly
expressed during host infection and would likely interact with the host. We will express these novel antigens
along with standard control CF and TP antigens from Coccidioides in a model organism (Escherichia coli) and
use the protein products to create an electrochemical sensor Molecularly Imprinted Polymer (MIP) diagnostic
assay. MIPs are a polymer that has been processed using a molecular imprinting technique which leaves cavities
in the polymer matrix with high affinity for a chosen ‘template’ molecule (in our case the antigens expressed by
E. coli). When paired with an electrochemical biosensor, MIPs can be the basis for a low-cost diagnostic tool
because they mimic biological recognition well enough to be called ‘synthetic antibodies.’ In total, this proposal
represents a unique pairing of advanced genomic data analysis and novel diagnostic development in an
important, yet understudied, fungal pathogen.

Public health relevance
The incidence of coccidioidomycosis (Valley Fever), caused by the highly infectious soil fungi Coccidioides posadasii and C. immitis, has been rapidly growing for decades with current statistics estimating 150,000 new cases annually in the United States. Serological diagnosis is the most common method, typically detecting the presence of antibodies (four tests on the market) or antigens (one test on the market), and both types of diagnostic tests are based on intellectual property owned by companies and thus no commercial provider of antigens or antibodies is available. Advanced diagnostic development approaches can help improve our ability to detect and diagnose infection and we propose to use both well-validated methodologies and innovative novel approaches to improve Valley Fever diagnostics.